CSHL 2022 Neurodegenerative Diseases: Biology & Therapeutics Conference

ABSTRACT
Neurodegenerative Diseases: Biology & Therapeutics
November 30 - December 3, 2022
This proposal seeks support for the biennial conference on Neurodegenerative Diseases:
Biology & Therapeutics, from November 30 – December 3, 2022 at Cold Spring Harbor
Laboratory (CSHL). The meeting brings together scientists who investigate both basic and
translational aspects of neurodegenerative disorders such as Alzheimer's disease, Parkinson's
disease, and amyotrophic lateral sclerosis. For many of these disorders, the molecular
pathways of the disease processes remain unclear and thus few biomarkers have been
identified. For other disorders, existing treatments are designed primarily to provide relief from
symptoms without addressing the biology underlying degenerative processes. Translational
research is therefore needed to develop and validate novel diagnostic strategies as well as new
therapeutics that might halt or stem disease progression, rather than simply alleviate symptoms.
The conference will advance knowledge in neurodegeneration by providing a forum where
scientists from distinct laboratories and institutions, both academic and industry, can exchange
findings, ideas, and seek collaborations. It will include sessions on convergent and divergent
pathways in neurodegenerative diseases, glial biology, therapeutic strategies, APOE and lipid
metabolism, cell biology, and protein homeostasis. For human studies seeking new treatments
for neurodegeneration to be informative, it is essential for scientists who research different
aspects of those treatments to meet regularly in a setting like CSHL to exchange data and
ideas. The 2022 CSHL meeting on Neurodegenerative Diseases: Biology & Therapeutics will
build on the successes of prior CSHL meetings to assemble an international gathering of top
scientists, discuss new developments in the field, and catalyze innovative research
collaborations, all of which will ultimately accelerate the pace of discovery.

Public health relevance
PROJECT NARRATIVE Neurodegenerative Diseases: Biology & Therapeutics November 30 - December 3, 2022 Neurodegenerative diseases exert a staggering cost to governments and societies, and thus have become an urgent concern to public health worldwide. The cost of Alzheimer's disease in the U.S. alone in 2020 has exceeded a quarter trillion dollars. Unfortunately, detailed understanding of the disease processes critical for effective therapeutic interventions for many such disorders remains sketchy. Thus, basic research of the disease process is needed to develop novel diagnostic strategies and new therapeutics that might halt or stem disease progression. The Cold Spring Harbor Laboratory conference on Neurodegenerative Diseases: Biology & Therapeutics will advance knowledge in the field by bringing together top scientists with expertise in disparate aspects of neurodegeneration in an excellent venue that will provide an ideal forum for catalyzing scientific interactions and collaborations to accelerate discoveries of effective therapeutics for the treatments of neurodegenerative diseases.